Origins of Diet-Induced Circadian Reprogramming and Plasticity

Humans adapt to the 24-hour day produced by the earth rotating on its axis. This internally-driven 24-hour (or,
“circadian”) adaptation in mammals produces rhythmicity in sleep, food intake, body temperature, and hormone
secretion, among other biological processes. The circadian clock exists in all cells and is heavily influenced by
zeitgebers (or, “time-givers”) such as food and light. Epidemiological studies reveal that environmentally- or
genetically-induced perturbation of our circadian clock leads to metabolic disease, in part by misaligning the
central clock in the brain with peripheral clocks. Nutrient challenge, such as high fat diet feeding, can
reprogram the liver circadian clock in a manner that misaligns it from the brain. The experiments of this
proposal are designed to test the hypothesis that high fat diet-induced circadian reprogramming is
accomplished by improper recruitment of the circadian protein BMAL1, in an insulin-dependent manner.
A high fat diet, which produces insulin resistance in the liver long term, will be used to address the
mechanisms underlying hepatic reprogramming. In particular, we will study the localization and chromosomal
recruitment of a key circadian transcriptional activator, the BMAL1 protein, under conditions of high fat feeding.
BMAL1 protein is necessary for cellular 24-hour rhythmicity but under high fat diet feeding, it gets recruited
inappropriately to DNA, altering 24-hour rhythmicity in target gene expression and subsequent circadian
metabolism in the liver. The mechanisms underlying this disrupted recruitment are not known but our
preliminary data suggest that altered BMAL1 recruitment may be a result of hepatic insulin resistance, as
BMAL1 chromatin recruitment and target gene expression are restored by the application of the anti-diabetic
thiazolidinediones. Secondly, the hypothesis that insulin signaling is the primary driver of hepatic circadian
reprogramming will be tested by using a combination of insulin resistant rodent models as well as by a class of
insulin-sensitizing drugs. These experiments will rely heavily on biochemical and bioinformatics approaches.
Rodents which lack the insulin receptor (a model of complete hepatic insulin resistance) will be analyzed in the
absence of high fat feeding for changes in BMAL1 recruitment as well as changes in chromosomal architecture
at BMAL1 target DNA. In addition, administration of the insulin-sensitizing drugs, the Thiazolidinediones,
commonly used in humans will determine whether high fat diet-induced circadian reprogramming is insulin-
dependent. Collectively, these models will reveal whether hepatic insulin resistance is necessary or sufficient
for diet-induced circadian reprogramming in the liver. These results will have important implications for how
other insulin-sensitive tissues respond to diet and the extent to which diet may control metabolic homeostasis
through synchrony of peripheral and central circadian clocks.

Public health relevance
PROJECT NARRATIVE Disruption of our 24-hour (“circadian”) clock leads to metabolic diseases including obesity and insulin resistance. Nutrients are a primary driver of peripheral circadian clocks and when nutrient input timing or quality is disrupted, peripheral clocks are compromised. The proposed experiments are designed to understand the mechanisms underlying diet-induced circadian control and the extent to which it depends on alterations in insulin signaling and sensitivity.